A high throughput alcohol screening platform (HT-ASP) incorporating cortical organoids.

ABSTRACT
Organoids are spontaneously formed heterogeneous, multi-cellular 3D tissues created by differentiating
progenitor cells (often induced pluripotent stem cells, iPSCs). Organoids-based MPS models currently
represent the most complex microscale, in vitro models of the human brain and the best in vitro model for drug
screening. However, establishing organoid MPS models is complex, requires significant hands-on time for
regular medium changes (often every 48 hours or less) and multiple differentiation mediums. Variability in
feeding schedule and handling protocols creates further unwanted variability in organoid culture, which is
difficult to overcome in a manual system. Moreover, alcohol is a complex insult with many, diverse effects on
the human brain. While this makes brain organoids heterogenicity valuable, no single organoid system
replicates the entire brain and therefore there is a need to determine how well a specific organoid can respond
to the alcohol insult.
Moreover, no single brain organoid replicates the entire human brain. Alcohol affects many parts of the brain
(Figure 1), including the basal ganglia, extended amygdala, and the prefrontal cortex. While the deep brain
structures are heavily involved in intoxication and the negative effects of withdrawal, preoccupation and
anticipation, the effects that most often lead to relapse in recovering patients, occur in the prefrontal cortex
which is responsible for conscious decision making and executive function. Current, approved medication for
the treatment of alcohol use disorder (AUD) focus on this area of the brain. Therefore, we propose that cortical
organoids are a useful model for screening potential therapeutics.
Overall, we propose to adapt our developed microphysiological system (MPS) platform for the development of
vascularized thick tissue and our organoid as a living biological sensor platform to create a high-throughput
alcohol assay platform (HT-ASP) that will incorporate automation to mature, maintain, and assay over 100
organoids in culture. The developed platform will provide a highly robust and genetically diverse platform for
screening multiple drug candidates.

Public health relevance
NARRATIVE Alcohol affects many parts of the brain and alcohol use disorder, colloquially known as alcoholism affects millions of people in the United States alone. Brain organoids provide a complex, human system in which to model both the affects of alcohol and to test potential treatments, specifically drugs. We propose to develop a robust, genetically diverse, and automated, high-throughput alcohol screening platform that will reduce the costs and complexity required to use brain organoids to help discover safe and effective drugs to treat alcohol use disorder.